Core A: Administrative Core

ABSTRACT – Core A: Administrative Core
The Administrative Core A of the Vaccines and Therapeutic Antibodies to Respirovirus, Rubulavirus,
Peribunyavirus and Phenuivirus (R2P2) ReVAMPP Center serves as the communication and
management control center of the R2P2 ReVAMPP Center. The main objective of this Core is to provide the
necessary support structures for effectively managing, coordinating, and evaluating the Center's activities. The
Core fulfills several critical functions: facilitating Go/No-Go decision making through quarterly evaluations of
Projects and Cores, maintaining a Scientific Advisory Board (SAB) to review and recommend strategic changes,
fostering collaboration and an interactive environment among Projects and Cores, and working with Project and
Core leads to identify synergistic collaborations and additional resources. The leadership team composed of
Sean Whelan, Anne Moscona, and Rino Rappuoli, along with the Associate Director, will form the senior
management team of the Center, overseeing research progress, financial resources, and addressing challenges.
The team will actively involve the Scientific Advisory Board, NIAID, and other stakeholders in decision-making
processes. The Administrative Core will work with the Data Management Core to enhance collaboration by
facilitating data sharing and integration. The Core will be instrumental for supporting interactions with the
industrial partners, and creating a clear path from research to product development and will also ensure financial
accountability and regulatory compliance, and monitor and evaluating the progress of research projects and
Cores with the active involvement of the SAB, reporting progress to the SAB and NIAID through the preparation
of annual progress reports. The Core will ensure that all Intellectual Property arrangements have been negotiated
and completed prior to sharing and distribution of resources. The Core will act as a liaison between the Center
and NIAID, coordinating visits between team members, SAB, and NIAID, managing publication submissions and
covering publication costs and travel to ReVAMPP meetings, and establishing and maintaining a publicly
accessible website summarizing the Center's activities. Overall, the Administrative Core plays a crucial role in
facilitating effective decision-making, collaboration, compliance, and progress evaluation, ensuring the
successful implementation of the ReVAMPP program. With an experienced leadership team and a well-defined
structure, we are equipped to effectively fulfill these responsibilities and ensure the success of the R2P2-
ReVAMPP goals.